The Role of Mesoaccumbens Dopamine in Pain and Prescription Opioid Addiction

This Veterans Affairs Career Development Award (CDA)-2 will provide support for academic career development
through mentored research and professional skills development in preparation for transition to an academic
research faculty position. Proposed activities will occur under the mentorship of Drs. Nicholas Gilpin, James
Zadina, Scott Edwards, and Tiffany Wills and will foster hypothesis-driven research and independent
investigation. Chronic pain affects >100 million American adults, costing the nation ~$635 billion every year in
medical treatment costs and lost productivity. Due to the high prevalence of chronic pain among Veterans,
treatment of chronic pain is a top priority of the Department of Veteran Affairs (VA), with prescription opioids a
critical first-line treatment for chronic pain patients. However, Veterans treated chronically with opioids for their
chronic pain may be vulnerable to developing opioid addiction and/or using illicit opioids to self-medicate pain
symptoms. Chronic pain and opioid addiction each produce functional abnormalities in the nucleus accumbens
(NAc), including dopamine (DA) deficits, which may be attributable to reduced cell firing of ventral tegmental
area (VTA) DA neurons projecting to the NAc. The NAc mediates the acute rewarding effects of drugs of abuse
via the mesoaccumbens pathway (VTA to NAc) and represents a functional terminus for ascending nociceptive
pathways. However, there remains a gap in our knowledge regarding how chronic pain and limited/escalated
opioid use interact to alter NAc neuronal excitability, drug intake, and pain sensitivity. The purpose of this project
is to examine overlapping brain biochemical mechanisms of chronic pain and opioid dependence that may
contribute to the worsening and potential interdependence of these two disorders. Our central hypothesis is that
chronic pain induces mesolimbic dopaminergic signaling deficits that drive the development of prescription opioid
(i.e., fentanyl) abuse, and fentanyl intake exaggerates pain-like outcomes in rats with chronic inflammatory pain.
Here we propose that I) chronic inflammatory pain increases fentanyl intake, and that fentanyl intake exaggerates
hyperalgesia in rats with chronic inflammatory pain, II) chronic inflammatory pain and fentanyl intake each
increase the intrinsic excitability of NAc neurons and excitatory transmission onto NAc neurons, and III) VTA-
NAc DA circuit activation and/or D2-like receptor agonist treatment each reduce hyperalgesia and escalated
fentanyl intake in rats with chronic inflammatory pain. These hypotheses reflect the order of the aims in this CDA
proposal. To investigate these hypotheses, we propose an innovative experimental strategy that compares the
effects of chronic inflammatory pain states on the electrophysiological properties of NAc neurons and behavioral
deficits (fentanyl intake/motivation, nociception) in animals given long access (LgA; 12 hrs) to fentanyl and short
access (ShA; 1 hr) to fentanyl. Finally, we will use chemogenetics and targeted pharmacotherapies to test the
effects of VTA-NAc DA circuit activation and D2-like receptor agonism on fentanyl intake/motivation and
nociceptive measures in rats with chronic inflammatory pain. Conclusions resulting from these studies will have
an important impact within both the pain management and addiction fields, as well as provide potential
pharmacotherapeutic strategies for VA populations suffering from chronic pain and opioid addiction. In addition,
an important feature of this CDA proposal is its provision of training in critical skills necessary for the applicant
to attain her long-term goal of becoming an independent biomedical researcher and leader in the field of pain
and opioid addiction research. Career development milestones and trajectories will guide her progression to an
independent VA research career and include a transition to independence in terms of behavioral, surgical,
electrophysiological, pharmacological, and chemogenetic techniques as well as a critical focus on professional
skills development. In summary, this CDA award will greatly facilitate the applicant’s transition to an independent
VA research position to continue future investigations into the biobehavioral mechanisms of chronic pain and
opioid addiction.

Public health relevance
Up to half of older U.S. military Veterans report chronic pain-related disabilities. In addition, military populations are developing degenerative pain conditions at much higher rates and at younger ages than civilians. There is a higher prevalence of chronic pain and opioid use reported in Veterans compared to civilian populations. Accordingly, Veterans treated chronically with opioids for their chronic pain may be vulnerable to developing opioid addiction (i.e. opioid dependence) and/or using illicit opioids to self-medicate pain symptoms. This project will examine overlapping brain biochemical mechanisms of chronic pain and opioid dependence that may contribute to the worsening and potential interdependence of these two disorders, with the ultimate goal of developing better therapeutic strategies for these devastating conditions affecting VA populations. Additionally, with the growing number of female Veterans treated by the VA for chronic pain issues, it is necessary to investigate new treatment opportunities for the benefit of both male and female Veterans.